Examining tissue-specific DNA methylation after prenatal exposure to arsenic among infants with spina bifida

PROJECT SUMMARY/ABSTRACT Arsenic contamination in drinking water continues to be a major health threat worldwide. An emerging hypothesis is that arsenic acts via the epigenome, the multitude of compounds that affect DNA transcription of specific genes but do not alter DNA sequence. Better understanding of this important potential mechanism of arsenic toxicity is essential to design strategies to prevent and treat arsenic-related diseases. Neural tube defects, including spina bifida and anencephaly, are common and severe birth defects that occur when the embryonic precursors to the brain and spinal cord do not properly develop. Neural tube defects are increasingly considered to be among the sequelae of arsenic exposure. In this R21 application, we test the hypothesis that arsenic's effects on the developing nervous system are mediated through the epigenome. We propose to use readily accessible nervous system tissue that is exposed as a result of the birth defect to test our hypotheses. In this application, we establish a new basic science-clinical science collaboration to determine DNA methylation patterns from various tissues from a human population of infants with myelomeningocele, a common and severe form of neural tube defect. Our clinical group is currently conducting an epidemiological study in Bangladesh to determine whether maternal arsenic exposure through contaminated drinking water increases the risk of myelomeningocele. We have recently started collecting discarded tissue from surgical closure of the myelomeningocele, and these samples provide a unique opportunity to investigate tissue- specific epigenetic patterns. We propose a series of pilot studies that will whole genome bisulfite sequencing (WGBS), a new and innovative method that enables investigation of DNA methylation at a single-nucleotide resolution, to examine DNA methylation in candidate genes known to be important in neural tube defects in the blood and nervous system tissue of affected infants. These high risk, high reward studies will identify genes that are differentially methylated in relation to arsenic exposure and phenotype, as well as test the hypothesis that neuroepithelial tissue provides a unique window into the study of human neural tube defects. These studies will also provide important preliminary data for future collaborative projects such as epigenome-wide association studies (EWAS). Such studies are highly likely to provide new targets for preventive interventions.

Public health relevance
PROJECT NARRATIVE Our studies aim to understand the epigenetic mechanisms of arsenic toxicity that contribute to neural tube defects. Among infants with myelomeningocele, we will use whole genome bisulfite sequencing (WGBS), a new and innovative method to examine DNA methylation, to identify genes that are differentially methylated in relation to arsenic and folate exposure. We will also use multiple tissues (dural tissue, blood, buccal cells) obtained from these infants to examine tissue-specific DNA methylation patterns.